Fibroblast-mediated resolution of basal metaplasia in lung fibrosis

Project Summary/Abstract
One of the hallmarks of severe fibrotic injuries of the lung is the appearance of metaplastic airway basal cells in
the damaged alveoli. In patients with idiopathic pulmonary fibrosis (IPF), this pathognomonic feature is
described as “bronchiolization,” which denotes the appearance of bronchus-like structures in the scarred
alveoli that leads to cystic remodeling in the lung. In this proposal, we seek to define pro-reparative
differentiation pathways in both the fibroblast and stem cell compartment that can be leveraged as therapy.
Our preliminary data demonstrated the appearance of an alveolar fibroblast population during fibrotic injury
resolution in mouse that expresses the extracellular hedgehog antagonist, HHIP, concurrent with a metaplastic
basal cell-to-alveolar type 2 (AT2) cell differentiation trajectory in the alveoli undergoing repair. Furthermore,
we generated a chimeric HHIP protein that demonstrated efficacy in promoting basal-to-AT2 differentiation in
vivo. Utilizing a combination of novel genetic tools to trace and delete HHIP+ fibroblasts, xenotransplant model
of human metaplastic basal cells, and a novel pharmacologic reagent made in our lab to target metaplastic
basal cell differentiation, this proposal will test the central hypothesis that HHIP+ alveolar fibroblasts emerge
after fibrotic injury to promote the restoration of alveolar progenitors from metaplastic basal cells. Finally, we
will determine whether HHIP can be leveraged as pharmacotherapy to reverse pathogenic remodeling seen in
IPF, and establish a humanized preclinical model to test the effect of therapeutics to reverse metaplastic
remodeling in the fibrotic alveoli. Successful completion of this proposal will define a stem cell lineage
trajectory that leads to reversal of remodeling seen in IPF, and provide preclinical studies to validate this
therapeutic strategy.

Public health relevance
Project Narrative The lungs of patients with idiopathic pulmonary fibrosis (IPF) contain areas of abnormal stem cells near scarred lung tissue that can drive disease progression. This proposal will explore how fibroblasts in the lung could potentially help turn abnormal stem cells back into normal stem cells in the areas of the lung that absorbs oxygen. Furthermore, we will test a new therapy derived from fibroblasts that could potentially turn abnormal stem cells back into normal stem cells in areas of fibrosis and determine whether we can reverse disease progression in a model of IPF.